Discovery of Chemical Probes and Therapeutic Leads, Phase II

Project Abstract
Nitrogen-containing heterocycles are ubiquitous in biologically active natural products and drug agents and are
found within 59% of FDA-approved human therapeutics. Novel N-heterocyclic natural products are potentially
important drug leads toward the treatment of human disease and new green synthetic methodology for their
laboratory synthesis are critically needed toolsets. This proposal merges the expertise of four independent
laboratories toward the goals of identifying novel N-heterocyclic natural products and generating new
electrosynthetic strategies toward their laboratory synthesis. The Jeffrey Laboratory (UNR) is executing targeted
metabolomics acquisitions and analyses in order to isolate and structurally characterize novel N-heterocyclic
natural products. The Chain Laboratory (UD) is developing electrosynthetic strategies toward the total syntheses
of these new natural products and the development of new electrochemical methodologies. The Hernandez–
Pagan Laboratory (UD) is generating an array of metal nanoparticle materials that will facilitate new
electrochemical bond-forming reactions toward our syntheses of N-heterocyclic materials. The Davidson
Laboratory (UD) will leverage machine learning and data-enabled approaches to systematically navigate the
vast number of potentially influential synthetic parameters during nanoparticle synthesis and electrosynthetic
tranformations to guide the development of sustainable synthetic approaches to N-heterocyclic natural products.

Public health relevance
PROJECT NARRATIVE This proposal seeks to develop a new data-driven structurally resolved approach to natural products discovery that will accelerate the development of bioactive small molecules. By searching for materials featuring structural scaffolds with established synthetic accessibility, and using those materials and machine learning to inspire more environmentally benign synthesis, the proposal will invert the normal workflow of natural products discovery and drug lead development which will be of high impact to human health outcomes.